METABOLIC PATHWAYS IN SHEWANELLA ONEIDENSIS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We have begun a comparative proteomics study of Shewanella oneidensis. The goal is to discover phenotypic difference in the metabolic pathways involved in the processing of metals. We plan to analyze several strains of the bacteria each grown under different conditions (i.e., challenged by toxic metals). The training component of this project provides laboratory research opportunities for undergraduates and graduates from Jackson State at the NCRR site.